Development and Maintenance for the Manufactured Food Regulatory Programs

Project Summary
The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food
Safety has been enrolled in the Manufactured Food Regulatory Program Standards (MFRPS)
and Rapid Response Team (RRT) programs since 2008. In that time the FDACS has
implemented many systems for both the RRT and MFRPS programs. This project proposes to
build on on those systems as the department continues to improve, maintain, and enhance
existing systems and moves forward with the implementation of the Food Safety Modernization
Act, specifically 21 CFR 117, and 21 CFR 112 (as it pertains to sprouts) as adopted by state
rule in 2017.
Proposed work for this project includes updating inspection and training systems, electronic
systems, and industry outreach efforts to meet the needs of PC for Human foods and sprouts
inspections, enhancements to learning management systems, and document control systems.
Proposed work, including the Food Protection Task Force and Special Projects, also includes
building and improving upon on the established foundation, and relationships of the RRT
program, improving the effectiveness and efficiencies of response coordination, communication,
and collaboration during food and feed emergency response. This cooperative agreement will
afford us the opportunity to maintain full conformance with the MFRPS and to share,
collaborate, and mentor other state programs as we continue develop creative and innovative
solutions for both the RRT and MFRPS.
The cooperative agreement will also afford us the opportunity to enhance the infrastructure of
the state MFPRS and RRT programs, and in doing so, will assist with improvements of other
manufactured food and rapid response programs on a national scale. The end project goal is to
strengthen consistency, effectiveness, and efficiencies of developed and new systems used to
enhance strengthening of the integrated food safety system, resulting in a safe food supply for
the public.
Page 1 of 1

Public health relevance
Project Narrative The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food Safety seeks to continue their involvement in the Manufactured Food Regulatory Program Standards (MFRPS), the Florida Integrated Rapid Response Team (FLIRRT), and the Florida Food Safety and Food Defense Advisory Council. FDACS is committed to continued improvement, enhancement, and maintenance of the manufactured food and RRT programs, as well as assisting with improvements of other programs nationwide. These improvements will strengthen the integrated food safety system, resulting in a safer food supply for the public.